Improving Influenza Vaccination Delivery Across a Health System by the Electronic Health Records Patient Portal

Abstract
Annual epidemics of influenza cause substantial morbidity in the US with up to 40,000 deaths/year and
many hospitalizations, emergency department visits, outpatient visits, and costs. The Advisory Committee on
Immunization Practices (ACIP) recommends annual influenza vaccination for all people above 6 months of
age. However, less than half of all Americans receive the influenza vaccine.
Two sets of interventions that can improve influenza vaccination rates include patient reminders (generally
by mail or phone), and enhancing access and ease of obtaining the vaccine. However, due to resource
limitations and difficulty scaling up reminders, only a small proportion of practices or health systems remind
patients about the need for vaccination, and few systems implement innovative strategies to ease access to
influenza vaccination.
A technological breakthrough that might overcome these barriers is the electronic health records patient
portal. Patient portals are secure, web-based communication systems, embedded within electronic health
records (EHRs), allowing patients and providers to communicate via email and the internet. Portal-based
reminder has the potential to raise vaccination rates for several reasons: the messages come from the
patient's provider, portal reminders are easily scalable, portal messages can be personalized by drawing on
information found in the patient's medical record, and portals can facilitate access by helping patients schedule
their own appointments for vaccination.
This study will implement and evaluate a portal reminder system for influenza vaccination across a large
UCLA-wide health system that serves >275,000 patients in 49 primary care practices, half of whom use the
portal. For Aim 1 we will adapt algorithms, educational messages, and protocols previously used for mailed or
phone influenza vaccine reminder/recall to create a patient portal research platform. For Aim 2, we will assess
the impact of portal reminders, and key design features of these reminders, on influenza vaccination rates and
costs using 3 sequential RCTs over 3 flu seasons. RCT #1 will test the optimal number of portal reminders (3,
2, or 1 vs. 0). RCT #2 will test the additional benefit of adding patient direct appointment scheduling to the
portal reminder system. RCT #3 will test the additional benefit of linking portal reminders with the EHR to
customize portal messages. For Aim 3 we will develop an adoption guide/toolkit for use by other health
systems. We will disseminate the portal reminder system in a network of Los Angeles Department Health
community health centers serving more than 30,000 low-income patients.
By study end we will have an advanced influenza vaccine portal reminder system, ready for dissemination.

Public health relevance
Project Narrative Two ways to raise influenza vaccination rates are to send reminders to patients (usually by phone or mail), and to improve access to vaccinations; yet these are not widely used. A technological breakthrough is the patient portal allowing health providers to communicate directly with patients by email. We will use 3 randomized clinical trials (in 3 seasons) of portal reminders across the UCLA Health primary care system, testing various customization features including allowing patients to directly schedule vaccine appointments and linking messages with patient-specific electronic health record data, to assess the impact of portal reminders on influenza vaccination rates and to assess cost-effectiveness.